Psychosocial Stress Due to COVID-19 and Vascular Aging in African-American Women

PROJECT SUMMARY
The novel coronavirus disease 2019 (COVID-19) global pandemic was arguably one of the most devastating
Public Health crises of the last century. In the US, African-Americans have been disproportionately impacted,
with overall rates of infection and mortality 2 to 4 times higher than those observed in Whites. Additionally, as a
direct result of closings of non-essential businesses and other entities, rates of unemployment and
underemployment also surged, and African-Americans have been significantly more likely than Whites to
report being underemployed or furloughed due to the pandemic. Unsurprisingly, given racial disparities in
COVID-19 mortality, national polls also find racial differences in reports of COVID-related loss, with African-
Americans more frequently reporting personally knowing someone who died from COVID-19 than Whites.
Because of this, it has been argued that, as a result of COVID-19, African-Americans have been
experiencing a “pandemic of stress” that will have a “dangerous impact” on their health and well-being
long after the virus itself is contained. Leveraging our previously funded cohort that assessed psychosocial
stress and vascular aging in early middle-aged African-American women, we will examine the degree to
which stressors resulting from, and related to, the COVID-19 pandemic might impact vascular
disease—the number 1 killer in the US-in this group. Middle-aged African-American women may be a
uniquely important group on which to focus, because: 1) they have increasingly high, but poorly understood,
rates of vascular disease relative to other race-gender groups; and 2) the long-term impact of the widespread
financial, employment and social stressors resulting from COVID-19 might be particularly deleterious for this
group, largely due to structural and contextual inequalities that pre-dated the pandemic itself. The proposed
project will examine linkages between overall psychosocial stressors (debt, financial stress, job stress,
interpersonal incivilities and mistreatment, loneliness), COVID-specific stressors (COVID-related financial
difficulties, COVID-specific parenting stressors, COVID-related loss) and prospective changes in vascular
aging (ambulatory blood pressure, arterial stiffness, inflammation) over 24 months in a cohort of 350 middle-
aged African-American women. Because we have pre-COVID assessments of a range of psychosocial
stressors, a major innovation of the proposed work is our ability to examine how pre- versus post-
COVID changes in exposure to overall psychosocial stress might prospectively impact vascular aging.
Importantly, we will capitalize on the considerable within-group heterogeneity in our cohort, to examine whether
our hypothesized associations are moderated by sociodemographic factors that might increase vulnerability
(socioeconomic status, single parenthood, marital status) or resilience (e.g., purpose in life, optimism, mastery,
social support) to psychosocial stress, in order to inform short- and long-term prevention efforts.

Public health relevance
PROJECT NARRATIVE The novel coronavirus 2019 (COVID) pandemic is the most significant Public Health crisis of the past century, and African-Americans are disproportionately impacted-- with rates of COVID-19 infection and mortality that are 2 to 4 times higher than those in Whites. Because most research on COVID-19 has focused on the physiological consequences of the disease, we know almost nothing about the psychosocial impact of COVID- 19, particularly in the most vulnerable groups. The goal of the proposed project is to examine the impact of COVID-related psychosocial stressors on vascular aging in a cohort of African-American women.